Predictive fitness models for influenza vaccine strain selection

Project summary
The human flu virus undergoes fast antigenic evolution driven by the challenge of the host immune system.
Circulating viruses are a moving quasi-species of high genetic and antigenic diversity, which is structured in
distinct clades representing niches with separate avenues of escape from human herd immunity. Specifically,
viral-immune co-evolution follows a Red Queen’s dynamical pattern of competing lineages, which is further
modulated by global transmission patterns, host population structure, and herd-immunity acquired by previous
infections and vaccination. This process poses a challenge for vaccine strain selection: to determine a single
strain from each of the four seasonal lineages to provide the best protection from the viruses that are expected
to dominate almost a year in advance.
Here we posit that shape and dynamics of the global viral population can be understood and predicted from the
underlying human population immunity. In this project, we will develop a comprehensive and objective
computational approach to provide a mechanistic understanding of the influenza virus-host immune interaction
on the host level, to quantify the selection imposed on the virus on the global evolutionary scales. Specifically, we
will build biophysical models, both for the B-cell and T-cell driven immune recognition of epitopes in a host, to
accurately characterize the immune structure of the human population to best represent the fitness effects acting
on the virus on the global scale. For the model of B-cell immune recognition (Aim 1), we will leverage diverse
antigenic human serology assays to prepare a detailed map of antigenic effects of mutations and epistatic
interactions. The data will be cross-mapped on the dataset of sequences of globally circulating viruses and our
detailed phylogenies for each of the four seasonal lineages. The T-cell immune recognition (Aim 2) will be based
on computational machine learning predictions of epitopes, combined with novel biophysically motivated models
for prediction of immunodominant antigens. Host population geographically diverse HLA diversity will be
accounted for estimating selective pressures imposed on the population of the virus.
These components, together with a component describing the selective pressure due to previous vaccinations,
will be used to optimize a joint fitness model (Aim 3). Information theoretic approaches will be used to optimize
and evaluate the predictive power of the combined model. We will objectively quantify the significance of each of
the components and validate the predictions on the historical sequence and epidemiological data. With the
resulting fitness model we will define principled criteria for vaccine strain selection, to optimize the coverage and
efficacy of the vaccine in the future populations of the of seasonal human influenza viruses.

Public health relevance
Project narrative In this project we will develop predictive fitness model that accurately accounts for immune recognition of influenza antigens and for the epidemiological factors that create the environment for the evolution of the virus, to quantify fitness effects that are imposed on the virus. Using machine learning approaches we will leverage large sequence and phenotypic datasets to propose objective criteria for the influenza vaccine strain selection.